Noncanonical activities of SETD7 in preventing prostate cancer progression andtherapy resistance

PROJECT SUMMARY
Background: Epigenetic dysregulation involving lysine methyltransferases and demethylases play a critical role
in the progression of prostate cancer (PCa) and its resistance to androgen deprivation therapies (ADT) and
androgen receptor signaling inhibition therapies (ARSi). Our prior research has demonstrated that LSD1
promotes oncogenic development by demethylating lysine 270 on FOXA1, a key pioneer factor in driving
castration-resistant prostate cancer (CRPC) progression, thereby enhancing its chromatin binding and enhancer
accessibility. In our recent report, we further revealed that SETD7, originally known as an activator of gene
transcription by methylating histone 3 lysine 4, specifically targets FOXA1-K270 for methylation, acting as a
negative regulator of the LSD1-FOXA1 epigenetic axis in PCa cells. Subsequently, we identified a tumor-
suppressive function of SETD7, noting that CRPC tumors with reduced SETD7 expression correlate strongly
with poor clinical outcomes. Additionally, we observed that SETD7 deficeincy leads to a redistribution of FOXA1
chromatin binding, facilitating the progression of prostate tumors and the resistance to ARSi.
Hypothesis/Objective: (1) We hypothesize that SETD7 is crucial in preventing tumor progression by negatively
controlling LSD1-mediated oncogenic activities in PCa cells. Thus, a reduction in SETD7 levels and activities
may allow PCa cells to become resistant to ARSi by adapting to LSD1-FOXA1-induced transcriptional
reprogramming. (2) We further hypothesize that the SETD7 deficiency in CRPC generates vulnerabilities that
can be intervened with epigenetic treatments designed to target LSD1-FOXA1-mediated epigenetic
reprogramming.
Specific Aims: Aim 1 is to assess SETD7 protein expression and its correlation with SETD7 targets, LSD1, AR,
and other key epigentic regulators in CRPC specimens, and to investigate AR regulation of SETD7 transcription.
Aim 2 is to delineate the mechanisms underlying SETD7's tumor suppressive activity, focusing on its role in
restricting FOXA1 chromatin binding and preventing reprogramming of the Super-Enhancer-driven transcription
network. Aim 3 is to target vulnerabilities induced by SETD7 deficiency and evaluate the effectiveness of these
treatment strategies in SETD7-deficient CRPC using cell line and patient-derived xenografts (PDXs).
Impact: Should this study succeed, its immediate outcome will be to elucidate the mechanisms through which
SETD7 exerts its noncanonical tumor-suppressive and transcription-repressive roles in PCa progression and
treatment resistance, as well as to pinpoint actionable targets for the development of therapies aimed at
combatting the aggressive subtype of CRPC characterized by SETD7 deficiency. Over the long term, the goal
is to translate these therapeutic strategies targeting SETD7-loss vulnerabilities into clinical trials for a well-
defined subset of CRPC patients, thereby enhancing patient outcomes.

Public health relevance
PROJECT NARRATIVE Alterations in a group of proteins that modify chromatin structure are key drivers of cancerous changes and resistance to hormone therapy in prostate cancer. We discovered that advanced prostate cancer resistant to treatment shows a significant decrease in SETD7, a chromatin modifying protein that helps prevent prostate cancer growth by uniquely modifying a cancer driver protein FOXA1 and disrupting its activity, leading to less aggressive cancer. Our research aims to investigate how SETD7 levels change in prostate cancer as it evolves and becomes resistant to treatment, understand how SETD7 prevents cancer growth, and create new treatments targeting the SETD7 deficiency in aggressive prostate cancer.